Biophysical, Topological, and Functional Studies of Endogenous Circular DNAs

Biophysical, Topological, and Functional Studies of Endogenous Circular DNAs
(PI: S.D. Levene)
Project Summary/Abstract
The existence of endogenous circular DNA elements, termed extrachromosomal circular DNA (eccDNA), has
been established in a wide range of organisms from plants to humans for close to fifty years. Until recently,
little was known about the functions, biogenesis, and sequence properties of these molecules. However, a
recent “explosion” in the field has begun to amass evidence that the mechanisms producing these species play
important roles in genome dynamics. The connection between eccDNA biogenesis and variations in DNA-
locus copy number generate cellular heterogeneity, which has important implications for healthy and
dysfunctional cells and major impact on cancer progression and treatment. This application offers an
unprecedented opportunity to fuse biophysical and genomic approaches that are crucial to advance eccDNA
research and builds on the PI's nearly thirty years of experience in DNA topology and nucleic-acid physical
chemistry. We will use an innovative, multi-faceted approach that combines biophysical and DNA-topology-
based techniques for DNA/chromatin isolation and characterization with leading-edge tools for genetic
analysis. Using standard and engineered human cell lines, we will define the roles of eccDNA topology (e.g.,
supercoiling), sequence, size, and nucleosomal organization in the biological activities of endogenous circular
DNAs. A major outcome of this work will be an advanced quantitative understanding of eccDNA biogenesis,
maintenance, organization, and biological function. In addition, we will identify structural properties unique to
eccDNA elements, which can be exploited for molecular therapeutics and other applications including
diagnostics.

Public health relevance
Biophysical, Topological, and Functional Studies of Endogenous Circular DNAs (PI: S.D. Levene) Project Narrative Circular DNAs, which are physically and topologically distinct from linear chromosomes, contribute to many biological activities including intercellular heterogeneity and, in particular, are associated with malignancies and chemotherapy-drug resistance. Understanding the structure and topology of these circular molecules, which distinguish them from linear-DNA counterparts, can lead to strategies targeting circular-DNA-specific properties. Thus, the study described in this application can provide valuable information to advance 21st– century therapies for cancer and personalized medicine.